Yale Center for Molecular Discovery Shared Resource

YALE CENTER FOR MOLECULAR DISCOVERY - PROJECT SUMMARY/ABSTRACT
Yale Center for Molecular Discovery (YCMD) is a core facility providing high throughput and high content assay
development, screening and hit validation services to the scientific community. The Center maintains and makes
available for screening a diverse collection of drug-like small molecules and genomic libraries. YCMD also
maintains a sophisticated infrastructure, including cutting-edge screening instrumentation and analysis
databases, to support high throughput assay design, testing, liquid handling and reformatting needs.
YCMD develops biochemical, cell-based, and model organism-based assays with both plate reader and high
content microscopy-based readouts. Highly trained and experienced staff offers the Center’s customers unique
and deep expertise in assay optimization, screening and validation. YCMD staff works closely with the members
of Yale Cancer Center (YCC) and other Yale laboratories to plan their programs, design, develop and miniaturize
assays, and execute robust screening experiments. As a YCC shared resource, YCMD offers services that span
a range of investigator-driven goals.
Established in 2003, the Center currently serves a very diverse and broad user base. During the fiscal year 2022
(July 2021 through June 2022), 34 laboratories have used YCMD. Twenty-five of these users (74%) were YCC
members. This Shared Resource was most widely used by Genomics, Genetics, and Epigenetics, but nearly all
the YCC Research Programs benefited from this core.
YCMD’s technologies and practical experience are applied to help YCC members address fundamental
questions in both basic and translational research. In pursuit of translational research, YCMD scientists support
siRNA and sgRNA/CRISPR screening to understand basic biological processes and help discover and validate
novel therapeutic targets. YCMD scientists also work closely with YCC members to help discover novel small
molecule probes that may serve as tool molecules or starting points for new therapeutics. Novel concepts are
developed in an efficient and cost-effective manner by mining pathways or identifying small molecule leads,
expanding the capabilities and impact of YCC investigators’ research.
The Specific Aims of YCMD are to: 1) Facilitate new lines of research for YCC members and other Yale faculty;
2) Make the YCMD suite of technologies, resources and expertise required for assay development and high
throughput screening accessible to a wide user base; and 3) Support early-stage development for translational
research programs.

Public health relevance
YALE CENTER FOR MOLECULAR DISCOVERY SHARED RESOURCE – NARRATIVE Not applicable.